The Health Impacts of Long-Run Exposure to Pollution in Adulthood and Later Life: Evidence from the US Army

OTHER PROJECT INFORMATION – Project Summary/Abstract
The Health Impacts of Long-Run Exposure to Pollution in Adulthood and Later Life: Evidence from the
US Army
A large body of observational studies link long-term pollution exposure to health harms, most notably mortality
from cardiovascular disease and lung cancer (Dockery et al. 1993; Pope et al. 2004; Laden et al. 2006; Miller et
al. 2007; Brook et al. 2010; Cerza et al. 2019; Lim et al. 2018; Qiu et al. 2018; Lipsett et al. 2011; Hoek et al.
2013, Beelen et al. 2014, Kaufman et al. 2016; Crouse et al. 2019). Since the original “Six Cities” study, many
methodological advances have been made to better isolate a causal relationship between long-term pollution
exposure and health. One factor that has received considerably less attention is the potential for confounding
due to people’s ability to choose where they live. People can move to particular locations based on, at least in
part, air pollution levels in that location. If people with more information and greater resources are more likely to
move to locations with lower pollution (Banzhaf and Walsh, 2008; Gamper-Rabindran and Timmins, 2011,
Finney, Goetzke and Yoon, 2011), it makes it challenging to distinguish whether poor health is caused by long-
term exposure to pollution or by the myriad of other factors correlated with pollution.
In this project, we aim to address these issues of residential confounding by focusing on military personnel.
Military personnel are an ideal group for this purpose because they are constrained in their ability to choose
residential locations to avoid pollution—their moves are determined by the needs of the Army. Therefore,
pollution exposures for this group are likely to be independent from the multitude of other factors that affect
health. Moreover, military personnel have uniform access to health care, such that the outcomes we study are
unlikely to reflect access to care or ability to pay, but instead reflect underlying demand for medical care due to
disease. Additionally, rich administrative data enables us to track the location and health care usage of personnel
over long periods of time. We can integrate administrative data from multiple sources, including the Total Army
Personnel Database, Tricare health care claims, and annual snapshots from the Veterans Health Agency in the
Department of Veteran’s Affairs.

Public health relevance
OTHER PROJECT INFORMATION – Project Narrative In this project, we aim to assess the effects of long-term pollution exposure on health by focusing on military personnel. They represent an ideal group for this study because they are constrained in their ability to choose residential locations, significantly limiting confounding threats, and because there is rich administrative data that allows us to track the location and health status of military personnel from young adulthood to middle age. Our estimates will provide vital new evidence for policy making purposes and regulatory standard setting.